IMSD at UC Davis

PROJECT SUMMARY/ABSTRACT
The overarching goal of our proposed IMSD at UC Davis Training Program is to increase diversity of
the biomedical research workforce via increasing the number of diverse students that complete PhDs in
biomedical-related science fields. For this, we propose to implement a comprehensive intervention program that
has rigorous research & education activities specifically for first-year graduate students. We anticipate
that our enrichment activities will increase diversity of the life science pipeline by facilitating successful
advancement of UC Davis PhD students to the next step of their biomedical research career. We propose to
select 10 graduate students per year to participate in this program, which has four major objectives. The first is
to increase the number of diverse students awarded PhDs in life science disciplines. In alignment with this goal,
we expect that (a) the rate of acceptance of underrepresented (UR), economically disadvantaged, and disabled
students into the target graduate groups will not be less than the rate for students not in those categories; (b)
the trainees’ oral and written communication skills will be enhanced; (c) the trainees’ selection for 2nd and 3rd
year slots on other UC Davis T32 programs will be increased, further expanding their interdisciplinary vistas; (d)
time to and success rate of IMSD Fellows in advancing to candidacy will be enhanced; and (e) at least 80% of
the Fellows will complete their PhD. Our second major objective of the proposed IMSD Fellows program is
enhancement of the mentor trainee relationship. This will be accomplished by (a) implementing an annual
workshop on mentor-trainee relationships which will include advice from successful senior graduate students;
(b) implementing/utilizing an annual IDP to improve productivity and clarity; and (c) having mentors take
specialized mentor training workshops. Our third objective is to develop outreach/communication and career
skills of the IMSD trainees via (a) implementing structured interaction with undergraduate UR, economically
disadvantaged and/or disabled students, providing relevant role models for these undergraduates; b) mentoring
of entering IMSD trainees by more senior R25 IMSD and IMSD T32 graduate students; and c) development of
important career skills by implementing experiential learning opportunities. The fourth objective is to utilize
program evaluations to continuously improve the program and provide expedient dissemination of the results.
This will be done by (a) implementation of evaluations throughout the Training Program; (b) publishing our
success and failures to enhance the effectiveness of other T32 programs;(c) annually revisit the program plan
incorporating improvements suggested by program evaluations; and (d) creation of an outstanding IMSD website
for diverse graduate students.

Public health relevance
PROJECT NARRATIVE The overarching goal of this IMSD Training Program is to increase diversity of the biomedical research workforce via increasing the number of diverse students who complete PhDs in biomedically-related science fields. For this, we propose to enhance and implement comprehensive intervention programs that have research and education activities for graduate students. We anticipate that our carefully developed enrichment activities will produce students who are well-prepared for their dissertation research, who will increase diversity of our PhD life science recipients, and who will successfully advance to the next step of their biomedical research career.